Sense4Safety Intervention

Abstract
Falls and fall-related injuries are significant public health issues for adults 65 years of age and
older. Over a third of older adults (OA) fall each year and 10-20% of falls result in serious
injuries such as fractures and head trauma. The annual direct medical costs in the US as a
result of falls are estimated to exceed $50 billion, and this estimate does not include the indirect
costs of disability, dependence, and decreased quality of life. This project targets community
dwelling OA with mild cognitive impairment (MCI). MCI is a leading risk factor for falls in OA.
Approximately 15%-20% of OA have MCI, and over 60% of OA with MCI fall annually – two to
three times the rate of those without cognitive impairment. We have developed and pilot-tested
an innovative technology-supported intervention called Sense4Safety to 1) identify escalating
risk for falls real-time through in-home passive sensor monitoring; 2) employ machine learning
to inform individualized alerts for fall risk; and 3) link `at risk' older adults with a coach who will
guide them in implementing evidence-based individualized plans to reduce fall-risk. The
purpose of this study is to assess the effectiveness of Sense4Safety in reducing fall risk with a
randomized clinical trial, and understand implementation factors to improve the scalability of
Sense4Safety in diverse community settings.

Public health relevance
Project Narrative The proposed research study aims to test the effectiveness of a technology mediated intervention to reduce fall risk for older adults with mild cognitive impairment. The intervention called Sense4Safety is designed to 1) identify escalating risk for falls real-time through in-home passive sensor monitoring; 2) employ machine learning to inform individualized alerts for fall risk; and 3) link older adults with a coach who will guide them in implementing evidence-based individualized plans to reduce fall-risk. Falls are a significant public health issue for older adults; therefore, the study is highly relevant to public health.